Developing a tick-borne Rickettsia isolate library.

Project Summary
Tick-borne diseases are an endemic and emergent public health threat in the US. The historic geographic range
of established tick vectors have expanded and new invasive tick species have been introduced over the last
decade. Additionally, novel tick-borne pathogens of human importance have been discovered at a rate unparallel
by other vector-pathogen complexes over the last 50 years. Unfortunately, our understanding about the
pathogenicity and ability to detect human tick-borne disease has been outpaced by the identification of new
species of tick-borne pathogens. This is especially true for spotted fever group Rickettsia (SFGR), which has
expreicenced a significant rise in disease and the identification of multiple novel pathogenic members of the
family since its initial discovery in 1920. We critically need new tools and resources to tackle this growing public
health problem. The overarching goal of this proposal is to develop a bank of Rickettsia spp. isolates from ticks
collected in the southern US and Central America to be used as a resource for further research into host-
pathogen interaction, pathogenicity, diagnostic, and vaccine development for SFGR. Our specific aims are as
follows: (1) Develop a Rickettsia isolate library using a cohort of previously collected and processed ticks from
the southern US and Central America, and (2) Conduct molecular characterization of Rickettsia spp. isolates
obtained from ticks collected in the southern US and Central America. We will utilize a cohort of >3,500 ticks
previously collected from Texas and Belize to conduct this research. We will select a stratified sample for culture
of 350 ticks from the 1,878 (53%) ticks that screened positive for Rickettsia that are representative of all
Rickettsia spp. and locations. We will conduct molecular characterization of the isolated species uing PCR and
sequencing of gltA, ompA, ompB, and htrA genes. Ultimately, we will make the isolate libarary available to the
broader scientific community for future research to advance the field. This study brings together a well-suited
team to tackle a growing public health problem. Our findings will serve as the foundation for many important
future studies to determine pathogenicity and develop effective diagnostic tests. Additionally, it will serve as an
important resource for the larger scientific community.

Public health relevance
Project Narrative Tick-borne diseases are an emergent public health threat in the US with expanding geographic ranges of established tick vectors, the introduction of invasive tick species, and the identification of novel tick-borne pathogens in the last decade. We critically need new tools and resources to aid in investigations into the mechanisms of tick-borne disease and develop innovative new controls measures. Our proposal aims to establish a library of Rickettsia isolates from a large geographically diverse cohort of ticks from the United States and Central America as a resource for future investigations including diagnostic assay and vaccine development.